EBV Genomics and Bioinformatics

CORE D – PROJECT SUMMARY
The goal of the EBV Genomics and Bioinformatics Core D will be to provide unified, EBV-centric functional
genomic methodologies and integrative bioinformatics support to all research Projects within the Program. Core
D proposes two Specific Aims: 1) develop and implement functional genomic approaches to study viral and
host genomes and epigenomes using diverse Next Generation Sequencing (NGS) approaches; and 2) provide
bioinformatic support for each Project through a centralize hub responsible for data management, quality control,
analysis, and transfer within the program. The scope of service will include: 1) providing expertise and capabilities
in genomic approaches including mRNA expression by RNA-seq, CHIP- and ATAC-seq library preparations,
DNA methylation studies by RBBS, and HiC ; 2) ensuring seamless coordination of ‘omics’ efforts across projects
as they develop new insights about EBV and performing integrative analyses to combine data from different
experiments across the various projects; and 3) assisting with final reports, abstracts, manuscripts, and future
funding proposals. Core D’s broad, long-term objective is: to provide leading-edge functional genomics and
comprehensive bioinformatics and data management support for the Program members, and proper deposit in
public database repositories.

Public health relevance
CORE D – PROJECT NARRATIVE The goal of the EBV Genomics and Bioinformatics Core D will be to provide an EBV-specialized functional genomic methodologies and integrative bioinformatics support to all research Projects within the Program. Core D proposes two Specific Aims: 1) develop and implement functional genomic approaches to study viral and host genomes and epigenomes using diverse Next Generation Sequencing (NGS) approaches; and 2) provide bioinformatic support for each Project through a centralize hub responsible for data management, quality control, analysis, and transfer within the program. The scope of service will include: 1) providing expertise and capabilities in genomic approaches including mRNA expression by RNA-seq, CHIP- and ATAC-seq library preparations, DNA methylation studies by RBBS, and HiC ; 2) ensuring seamless coordination of ‘omics’ efforts across projects as they develop new insights about EBV and performing integrative analyses to combine data from different experiments across the various projects; and 3) assisting with final reports, abstracts, manuscripts, and future funding proposals. Core D’s broad, long-term objective is: to provide leading-edge functional genomics and comprehensive bioinformatics and data management support for the Program members, and proper deposit in public database repositories.